Variable Intensive Early Walking post-Stroke (VIEWS)

Project Summary
The objective of this Phase II clinical trial is to identify how exercise training parameters, particularly the
specificity and intensity of stepping practice, influence long-term mobility outcomes in patients with subacute
stroke. Previous work indicates these variables can influence the efficacy of training interventions in
individuals without neurological injury, with some data to support their utility in chronic stroke. However,
studies that systematically assess the independent and combined effects of these principles in individuals early
following stroke are sparse. This critical research gap impedes clinical translation, and current clinical
practices remain adherent to traditional theories of rehabilitation, including lower intensity interventions focused
on underlying impairments. Additional concerns of providing only high-intensity walking training revolve around
the lack of attention toward movement quality will result in use of compensatory movement strategies that
could be reinforced with repeated practice, or that other risks of cardiovascular events should preclude high-
intensity training. Unfortunately, there is little data to support these hypotheses, and our studies suggest that
application of these training parameters can strongly influence walking function, as well as improve underlying
impairments and improve gait kinematics. Our approach is to characterize the effects of these training
variables on recovery of locomotor function and quality, as well as changes in impairments and other mobility
tasks in patients early post-stroke, in an effort to evaluate whether such training influences neurological
recovery or whether patients utilize compensatory strategies. In this 2x2 factorial RCT design, Aim 1 of the
study will characterize changes in mobility function associated with manipulation of specific and intensity of
exercise interventions. We will evaluate functional measures of gait speed and endurance, spatiotemporal
symmetry, as well as measures of cardiopulmonary fitness. We postulate that combined application of high-
intensity, task specific stepping practice will result in significantly greater increases in locomotor measures as
compared to lower intensity or non-specific training paradigms. In Aim 2, we will characterize the changes in
impairments (strength) and other mobility tasks (balance, sit-to-stand transfers) to determine whether stepping
intervention can mitigate the major impairments underlying post-stroke impairments. Quantitative measures of
volitional strength will be the primary outcomes. In Aim 3, we will characterize changes in community mobility
and quality of life, the later of which can inform us about cost-effectiveness. Overall, these results have
potential implications on the delivery of effective exercise interventions in person with subacute stroke.

Public health relevance
Project Narrative The proposed research will evaluate the individual and combined effects of task-specificity and intensity of rehabilitation interventions on locomotor function, community mobility and quality of life in patients with subacute (1-6 months) post-stroke. The primary hypothesis is that practice of specific walking tasks early post- stroke at very high intensities will maximize health and function.